Training Core

Enter the text here that is the new abstract information for your application.
The goal of the Harvard Kidney, Urology and Hematology Training Institute’s (HKUHTI) Training Program is to educate the next generation of leaders of KUH research by leveraging the intellectual, collaborative, and physical resources of our rich Boston ecosystem. Five partnering institutions request support for a TL1 Training Core to fund 10 pre- and 24 postdoctoral trainees in the steady state of the grant (after some adjustments in the first year taking into account the end of existing T32 grants). Trainees will benefit from HKUHTI-specific, as well as collaborative training curricular offerings that will be tailored to the trainee’s individual scientific and career goals. The HKUHTI will employ a rigorous selection process that will result in appointment of a scientifically-varied group of trainees from across the country to a program that provides rigorous training with a world-class roster of mentors in KUH fields. Trainees will benefit from a primary mentor and an individual oversight committee (IOC) throughout their tenure in the program. The HKUHTI will expose trainees to a range of innovative research opportunities, including those offered by established mentors, and will leverage a clinical and translational research accelerator, the Harvard Catalyst. The TL1 will address many identified challenges to training the next generation of KUH research leaders and will build on a strong history of success in developing and retaining leaders in KUH biomedical sciences. The requested positions will bring together K, U, and H across pediatric and adult divisions. The TL1 is closely linked to the U2C, incorporating rich Professional Development and Network Cores, and the supported trainees will benefit from a robust Administrative Core with a digital Hub, oversight committees, and evaluation infrastructure. Formalized structures are established for recruitment, selection, and retention, as well as mentor and trainee selection and evaluation. The TL1 will focus on offering trainees the knowledge needed to perform state-of-the-art science and prepare for a productive and rewarding career in KUH fields. Additionally, the TL1 is structured to provide oversight to trainees and ensure that the trainee, mentor(s), and IOC co-develop an Individualized Training Plan in a cooperative manner, such that the needs, emerging research interests, and future career of the trainee are always at the center of their training experience. The structure of the TL1 program was intentionally designed to address seven major challenges identified by surveying the trainees (see Training Plan). In addition, the HKUHTI will benefit from validated evaluation tools to collect data and address emerging trends and scientific challenges to ensure that trainees, mentors, and the entire HKUHTI community achieve measurable personal, professional, and scientific growth.

Public health relevance
Conservatively, it is estimated that over 50 million Americans suffer from kidney, urologic, and hematologic diseases, many of whom die from these devastating disorders every year. Our Program is designed to train the next generation of scientists to find treatments and cures for millions of patients who are waiting for answers.